Gut Microbial Functions that Impact Multiplex and Non-multiplex Crohn’s Disease Risk.

Project Summary/Abstract
The cause of Crohn’s disease (CD) is believed to be rooted in the interactions between genetic susceptibilities
and exposures to environmental factors, such as specific gut microbes. Unfortunately, the complexity of these
interactions makes it difficult to understand what portion of CD risk is modifiable, and specifically whether gut
microbiome compositions can be altered to overcome one’s underlying and fixed genetic predisposition. This
proposal will generate additional data for an ongoing study addressing whether individuals at high genetic risk
for CD, but who never develop the disease, harbor transferrable gut microbial signatures that mediate disease
protection. Aim 1 of this proposal entails the generation of shotgun metagenomic sequencing data on samples
already collected from multiplex CD families – with the rationale that families, sharing common living
environments, meals, and behaviors, will minimize frequent confounders of human microbiome studies.
Individuals have been stratified by a polygenic risk score to identify those at highest genetic risk but remain
disease-free, and who are hypothesized as being most likely to harbor CD-protective intestinal microbes. The
generated shotgun sequencing will allow us to determine bacterial community functions and thus integrate our
16S sequencing and fecal metabolomic data in an effort to develop a mechanistic understanding of the
relationship between the gut microbiome and CD development. In Aim 2, we will leverage our access to pre-
generated multi-omic data from a large biobank to extend our investigation beyond a multiplex family context.
The data generated in this proposal, therefore, will provide key insights to our study of microbially-mediated
modulators of CD risk and disease activity.

Public health relevance
Project Narrative Characterizing the gut microbiome of those who have never developed Crohn’s disease despite high genetic risk may allow a greater understanding of the microbial contributors to disease risk. To develop mechanistic insight, we will generate shotgun metagenomic sequences, which we will integrate with the existing 16S and fecal metabolomic results of an ongoing study of multiplex Crohn’s disease families. Findings will be validated through analysis of a large Crohn’s disease biobank and will further allow us to determine if study results are applicable outside of a multiplex context.